Roles of gut-breast axis in breast pathophysiology

Microbiome impacts cancer development and therapeutic efficacy. In addition to the guts, microbes reside in
different tissues influencing the pathophysiology of the tissue microenvironment. These tissue-resident
microbes are largely attributed to translocation of gut microbes. In the breast, such passage is termed ‘gut-
breast axis’, helping establish microbiotas of breast tissue and milk. Nevertheless, gut-breast axis has been
mostly conceptualized around pregnancy, and it is completely unknown whether this axis indeed exists outside
pregnancy to impact breast health and carcinogenesis. Our long-term goal is to dissect how microbiome
contributes to breast pathophysiology. Especially, the objectives of the present study are to determine i)
whether gut-breast axis occurs on a regular basis; ii) whether this involves discrete sets of bacteria for healthy
cohorts vs. cancer patients, and iii) what are their roles. Our central hypothesis is that gut-breast axis takes
place on a regular basis, involving distinct sets of bacteria to confer anti-tumor effects on healthy cohorts vs.
pro-tumor effects on cancer patients. The proposed research is based on our preliminary studies allowing us to
harvest specific gut microbiotas from tumor-protected or -susceptible animals. We reported that supplementing
sepiapterin (SEP)—the endogenous precursor of tetrahydrobiopterin (the cofactor of nitric oxide (NO)
synthase)—normalized arginine metabolism and improved the immunogenicity of HER2-positive mammary
tumors. We then orally applied SEP to mice prone to HER2-positive mammary tumors and saw strong tumor
prevention. These mice also showed increases in NO levels and NO-producing bacteria in the guts. Besides,
extracts of these gut bacteria activated innate immune cells, suggesting the roles of these gut bacteria in anti-
tumor immunity. Here, we will determine whether these gut bacteria physically translocate to the breast to exert
tumor preventative effects. Our hypothesis will be tested through two SPECIFIC AIMS: 1) Determine whether
gut microbiotas of a) tumor-protected vs. b) -susceptible mice exert anti-tumor vs, pro-tumor effects; and 2)
determine whether distinct sets of gut microbes are translocated to mammary glands to exert anti-tumor vs.
pro-tumor effects. In Aim 1, we will transplant gut microbiota of a) tumor-protected (SEP-treated) or b) -
susceptible (DMSO-treated) HER2 mice into recipients and give the inverse drug treatments. We will test
whether the transplanted microbiotas antagonize the treatments. In Aim 2, gut microbiota of a) tumor-protected
(SEP) vs b) -susceptible (DMSO) mice are differentially labeled, and the 50:50 mixture is given to the recipients
undergoing SEP or DMSO treatment. Labeled microbes are analyzed for their gut-breast translocation; their
ratios in the breast; and the contributions of breast microbiota to the drug effects. The proposed study is
innovative because this is the first time to corroborate gut-breast axis and its contributions to breast
pathophysiology. The study is significant because it will have a positive translational impact by justifying the
development of a new breast cancer treatment or prevention strategy focused on breast microbiota.

Public health relevance
PROJECT NARRATIVE Breast-resident microbes are proposed to be largely attributed to translocation of gut microbes and play critical roles in regulation of breast pathophysiology; however, t here have been mostly correlative and speculative studies for the roles and origins of breast microbiota. The proposed project aims to substantiate the direct roles of breast microbiota in breast pathophysiology. The proposed study is relevant to public health because it will justify a new breast cancer treatment or prevention strategy focused on breast microbiota.